Minnesota Training Program in Virology

Project Summary/Abstract
This is a competitive renewal of the “Minnesota Training Program in Virology” following a highly productive
funding period. Discoveries in virology research have led to many fundamental insights into molecular and
cellular processes of cells, basic mechanisms of viral replication and pathogenesis, and strategies for how host
cells respond to viral infection (i.e., virus-host interactions). Viruses and their capacity to cause serious
diseases and death have had a profound impact on the history of humanity and continually threaten global
health and economic stability. This training program utilizes 32 accomplished trainers, who are conducting
research on a wide variety of important viruses. The Institute for Molecular Virology (IMV) serves as the focal
point for virology research at University of Minnesota (UMN) and has championed virology research as a
critically important university investment at a time of declining resources. Such investment includes a 80,000-
square-foot, $63 million Microbiology Research Facility that opened in 2015 as well as $14 million for additional
research infrastructure in the Biomedical Discovery District in the past 8 years.
Key highlight's of the training activities of our program include implementation of foundational coursework in
virology as well as a wide-range of IMV-sponsored activities attended by both trainees and preceptors that
provide important intellectual, technical, and career development opportunities (i.e., weekly Virology Journal
Club, monthly IMV Research in Progress seminars, quarterly IMV Innovations in Virus Research Lecture
Series, annual UMN-Mayo Distinguished Lectures in Virology & Gene Therapy, the IMV Educational and
Career Development Series, the annual IMV Symposium, a collaborative `Wisc-e-sota' T32 symposium, and
annual sessions in Responsible Conduct in Research). Trainee participation in these training program activities
have fostered the exchange of ideas and stimulated collaborative projects. Oversight of trainee progress is
monitored on multiple levels, including yearly evaluations by the training program's executive committee.
Outstanding predoctoral trainees are attracted to the UMN. From this pool, outstanding predoctoral trainees
are recruited to trainer labs by the individual strength of each trainer's research program. Trainee recruitment is
enhanced by the breadth of career development opportunities provided through the IMV that include the
hosting of national and international virology meetings that brings students – including underrepresented
minority students – to our campus to develop long-lasting interactions with all members of our virology
research community. Despite being a relatively young training program, we have a strong record of training
achievement. To fulfill our training mission with our available resources, we request support for 6 predoctoral
positions per year for the next 5-year funding period.

Public health relevance
Project Narrative The training of young scientists that will become the next generation of virologists is essential for our nation's capacity to respond to existing, emerging, and future viral diseases. Furthermore, research on viruses continues to lead to fundamental discoveries in biology. Through the Institute for Molecular Virology and this T32 program, the University of Minnesota-Twin Cities campus has established itself as a leader in virology research, with particular strengths in HIV, influenza virus, herpesviruses, along with emerging and other highly pathogenic viruses.